Genetic Basis of Aortic Aneurysms/Dissections

DESCRIPTION (provided by applicant): The major disease processes affecting the aorta are aortic aneurysms and dissections. Aortic aneurysms are a major health problem in the United States, representing the I3th major cause of death, accounting for nearly 15,000 deaths annually. Ten to twenty percent of all aneurysms result from a genetic predisposition for the disorder. Although some familial aneurysms are due to inherited defects in extracellular matrix proteins, including Marfan syndrome and Ehlers-Danlos syndrome type IV, the majority of inherited aneurysms occur as an isolated cardiovascular abnormality, segregating in families as a monogenic autosomal dominant disorder. We have identified 25 families with autosomal dominant inheritance of thoracic aortic aneurysms and dissections, in whom the disease is characterized by variable expression and decreased penetrance. Using DNA obtained from family members and polymorphic markers spaced throughout the human genome, we have mapped a defective gene causing the disorder in 12 of these families to 5 Mb region at 5qI3-14. Dr. Craig Basson and his colleagues (Cornell University Medical College) have mapped a second locus for familial aneurysms in one large family to 11q23. We have confirmed further genetic heterogeneity for this disorder by the identification of families in whom the inheritance of the phenotype is not linked to the two identified loci. The long-term goal of the proposed project is to identify the mutant genes that predispose an individual to thoracic aortic aneurysms or dissections. The specific aims are the following: (1) to identity characterize, and collect samples from families with thoracic aortic aneurysms and dissections; (2) to identify the third locus for thoracic aortic aneurysms and dissections; (3) to narrow the critical interval at 5q 13-14 and identify candidate genes; (4) to screen for mutations in candidate genes using samples from families with autosomal dominant inheritance of thoracic aortic aneurysms and dissections. The proposed studies will identify the defective gene at a major locus for thoracic aortic aneurysms and dissections. The mapping of a third locus responsible for the disease will be determined, which is the first step towards elucidating other gene defects responsible for this disease. Identification of the genetic etiology of aortic aneurysms and dissections will enable preclinical diagnosis in families at risk. In addition, identification of the defective genes will lead to the development of experiment models of vascular pathology to increase understanding of the molecular pathology and provide the basis for rationale intervention.